Families for STEM Success: Mentoring LatinX Parents to Mentor and Support their STEM Students

Biomedical discoveries and public health clearly benefit from a diverse biomedical workforce.
Latinx parents are a largely untapped, and potentially powerful, resource for decreasing Latinx
student flight from the biomedical science career path. Behavioral science research has firmly
established that developing an identity as a scientist is a strong predictor of persistence on the
scientific research career path, yet little is known about how Latinx science majors balance their
scientific and ethnic identities and how parental support, and mentorship could foster identity
balance. The long-term research goal is to understand the impact of balancing science and ethnic
identities on attrition from the biomedical science career pipeline, and to test the utility of an
intervention designed to foster identity balance. The proposed research employs a quasi-
experimental, matched control, longitudinal design, to measure the impact of an intervention
program with parents of two cohorts (2020-2021 and 2021-2022) incoming Latinx biomedical
science majors. The specific aims are: 1) to measure the immediate impact of the workshop on
LatinX parents’ knowledge of and attitudes about science, the value of a science degree, and the
compatibility between scientific research and Latinx heritage. 2) to measure the impact of the
parental intervention on the short and long-term academic persistence and success of Latinx
biomedical science students. 3) to measure the impact of the parental intervention on students’
science identity across time, and the balance between their science and Latinx identities, and 4)
to assess the degree to which the effects of the parental intervention on short and longer-term
academic outcomes are mediated through scientific-Latinx identity balance. An early
intervention with parents has the potential to alter students’ social context to support identity
balance. This project is significant because it will provide a theory-driven rigorous empirical
understanding how parental education and support can help Latinx biomedical science students
achieve academically and balance a strong Latinx identity with an emerging science identity.
This parent intervention programs could significantly increase the pool of qualified Latinx
doctoral program applicants in less than a decade.

Public health relevance
Biomedical discoveries and public health clearly benefit from a diverse biomedical workforce, and LatinX parents are a largely untapped and potentially powerful resource for decreasing LatinX student flight from the biomedical science career path. This project will provide a theory-driven rigorous empirical understanding of how parental education and support can help LatinX biomedical science students achieve academically and balance a strong LatinX identity with an emerging science identity. This parent intervention program could significantly increase the pool of qualified LatinX doctoral program applicants in less than a decade and increase the diversity of the biomedical science workforce by 2040.